Determining Optimal Treatment Intensity for Children with Language Impairment (LI)

Project Summary/Abstract This urgent revision will determine the optimal treatment intensity for children with language impairment (LI), provided via telepractice platforms, by systematically manipulating treatment dose and frequency. This study will also investigate the moderating influence of the home environment on children’s outcomes. This study aim is urgent in that over 1 million children with LI are no longer receiving language services in the public schools, as prescribed by their IEPs, due to COVID-19. Children instead are either receiving supplemental resource packets or receiving therapy via telepractice — a grossly understudied platform for service provision for this population. Preliminary studies of children with LI in the public schools suggest that children with LI who received high frequency/low dose treatment (or low frequency/high dose) made better gains over time than children receiving the extremes (overall low or high intensity of treatment; Schmitt et al., 2017). These preliminary findings are correlational in nature; the current study aims to manipulate both parameters of intensity (dose and frequency) to determine not only the interactive influence of dose and frequency on children’s gains, but also the extent to which factors of the home environment — now a primary learning environment for school age children — influence the dose and frequency required to realize language gains. To address these aims, the proposed study will utilize the methods proposed in the parent study of optimal treatment intensity now on a telepractice platform. Participants (60 children with LI recruited from two US states) will be randomized into one of two frequency conditions (massed vs spaced) in which they will receive a word learning intervention previously tested through NIH funding by Holly Storkel and colleagues (e.g., Storkel et al., 2017). The intervention identifies 60 new vocabulary targets which are presented to children within story book readings using rich vocabulary intervention strategies. For the purposes of the proposed study, each vocabulary target (n = 60) will be randomized to one of six possible dose exposures (0, 4, 8, 12, 16, 20) for each child. SLP interns will deliver the manualized word learning intervention in one-on-one sessions for 10 weeks via telepractice platforms. Comprehensive measures of the child’s home environment will be collected before treatment, all via questionnaires and online interviews. Children’s vocabulary skills will be measured via telepractice at three time points: pre-treatment, immediate post-treatment, and 6-months post treatment to assess the impact of the intensity regimens on outcomes. Analyses will specify a dose-response curve to identify the point of optimal gain children receive from treatment as well as moderating influences of the home environment. Findings will immediately inform practice for school-based SLPs during the COVID-19 crisis as well as provide intensity parameters and familial considerations for future clinical trials.

Public health relevance
PUBLIC HEALTH RELEVANCE: Due to COVID-19 pandemic, over 1 million children in the US are now receiving speech-language therapy services at home and many via telepractice platforms, and current epidemiological models suggest that the crisis could take 18-24 months to fully resolve. Furthermore, children are now receiving language therapy in their home environment; empirical and theoretical research suggests that the home environment is now poised to exert impacts on children’s learning. As such, understanding the optimal levels of treatments that will improve children’s language skills, as proposed in the current study, is critical to efficiently and effectively mitigating the immediate and long-term effects of LI especially during this COVID-19 pandemic.